Kalirin and Osteocyte Dysfunction: Implications Across Skeletal Sites and Experimental Periodontitis

SUMMARY/ABSTRACT
The goal of this study is to elucidate how Kalirin, a multifunctional GTP/GDP exchange factor, regulates osteocyte
function and bone mass across various skeletal sites, with a particular focus on periodontal bone. Osteocytes,
the most abundant bone cell type, play a key role in bone remodeling, yet the specific mechanisms governing
their function remain unknown. Mice with global Kalirin deletion (Kal-KO) display low bone mineral density,
attributed in part to dysfunctional osteocytes as shown by decreases in osteocyte morphology and dendrite
length, altered expression of osteocyte genes and an increase in osteocyte apoptosis in cortical and trabecular
bone. We found dental, craniofacial and alveolar deficiencies in global Kal-KO mice. Given that osteocyte viability
is linked with the pathology of periodontitis, we hypothesize that osteocyte specific deletion of Kalirin will
decrease bone mineral density across different skeletal sites and exacerbate bone loss in a mouse model of
experimental periodontitis. Using osteocyte-targeted Kalirin knockout mice (Kal-Dmp1Cre), we will examine
changes in bone mass and architecture as well as osteocyte morphology, viability, and function across different
skeletal sites, and in experimental periodontitis induced by ligation of maxillary molars. In Specific Aim 1, we
will characterize the effects of osteocyte-targeted Kalirin deletion on bone mass and architecture at craniofacial,
periodontal, spine, and femoral sites using µCT, histology, and histomorphometric analysis. Changes in
osteocyte morphology and function will be investigated through histological staining of tissue and analysis of
primary osteocyte morphology and gene expression in vitro. In Specific Aim 2, we will investigate if Kalirin
deficiency in osteocytes exacerbates periodontal bone loss during experimental periodontitis. We will perform a
ligature-induced bone loss study in osteocyte-targeted Kalirin deletion (Kal-Dmp1Cre) compared to control (Kal-
FF) mice. Bone changes will be analyzed by µCT, histology, and histomorphometric methods. In addition, in situ
changes in the expression of osteocytic genes and inflammatory cytokines in LIP maxillae and control maxillae
from these mice will be performed by RNAscope and complemented with analysis of gingival crevicular fluid.
Both male and female mice will be used for all studies. These studies aim to enhance the overall understanding
of Kalirin’s role in osteocyte function and bone health at different skeletal sites, potentially leading to new
therapeutic targets for preventing bone loss and improving patient care, particularly in the context of periodontitis
and other bone loss diseases. The mentorship, training, resources and facilities available to me during my
journey towards my DDS/PhD will ensure a positive trajectory towards my future career as an independent dental
clinician scientist.

Public health relevance
PROJECT NARRATIVE This study aims to better understand the role of the unique protein, Kalirin, in osteocyte function and bone mass regulation across varying skeletal sites. Knowledge gained about how Kalirin affects bone homeostasis and contributes to bone loss diseases such as periodontitis can inform the future development of targeted therapeutic strategies to prevent or reverse bone loss at different skeletal sites. Closing knowledge gaps associated with osteocyte function and bone remodeling in health and disease is essential to ultimately improving patient quality of life.